Human Immune Monitoring Center (HIMC) Core

PROJECT SUMMARY
The Human Immune Monitoring Center (HIMC) has been a comprehensive resource for immunological assays
at Stanford for fifteen years. The HIMC Core will leverage this facility and its robust infrastructure to provide
biobanking, assays, and data organization services to the CCHI projects. Coordinating with the Clinical Core,
blood samples will be processed for PBMC, serum, RNA, and DNA, and biobanked according to optimized and
standardized procedures. Together with the existing inventory of many thousands of specimens from previous
CCHI and HIPC studies, these samples will be distributed to CCHI projects as needed, using an existing online
portal to request specific samples, with approval from an oversight committee. State-of-the-art, standardized
immune assays will also be applied to the CCHI samples, including CyTOF mass cytometry, multiplexed Luminex
and Olink cytokine analysis, hemagglutinin inhibition, phospho-flow cytometry, and whole blood RNAseq, to
provide comprehensive immunological data. As required for specific CCHI projects, custom Luminex panels and
single-cell multi-omics assays (BD Rhapsody, Mission Bio Tapestri, Parse Evercode, and/or Fluent PIPseq) will
be performed. Finally, the HIMC Core will integrate data from all standard HIMC assays with clinical and
demographic metadata using the online database, Stanford Data Miner (SDM). Existing scripts will then allow
formatting of data from SDM into ImmPort templates for samples, persons, and assay results.
The HIMC Core will create a valuable database of clinical specimens and comprehensive immunological data,
that will not only serve the needs of the CCHI U19 projects, but many other projects for years to come.

Public health relevance
We have assembled a broad and highly accomplished team to continue our investigations of Influenza and SARS-CoV-2 vaccination and infection, particular focusing on subjects that are vulnerable and seeking a deeper understanding of the effects of specific antibody glycosylation and specificity, bioinformatic signatures of pan virus responses and human immune organoids and the tissues and organs they interact with.